Core D: Long-term Follow-Up

PROJECT SUMMARY
This core supports Projects 1 – 3 by collecting long-term follow-up data for patients who have had
hematopoietic cell transplantation (HCT) or genetically modified T cell therapy at the Seattle Cancer Care
Alliance (SCCA), University of Washington (UW) or Seattle Children's Hospital (SCH) under protocols
developed at the Fred Hutchinson Cancer Research Center (FHCRC). The services of this core unit address
several closely related areas: identification and management of late complications, data and research sample
collection, database assembly and evaluation of the efficiency, accuracy, quality and utility of the data
collection and the system in which the data are stored. We have developed several mechanisms to support
this overall goal.
1. We will collect long-term data focused on survival, therapy-related complications, and health relevant to
the clinical research studies sponsored by this grant. This includes the prospective cohort of patients to
be enrolled in studies described in Projects 1 – 3 of this grant application, some of whom will be
receiving genetically modified cells and thus follow-up for at least 15 years after treatment is
recommended. For this purpose, a system has been established to track and maintain contact with
patients and referring physicians so that data can be collected at specified time points after treatment.
2. We will assist investigators in obtaining information and research biospecimens that are not routinely
collected but are needed for individual research projects.
3. We will continue to identify barriers that interfere with long-term follow-up of geographically dispersed
patients and develop methods to overcome these barriers.
4. We will continue to evaluate the research methods employed in data collection and database
management, including the efficiency, reliability, validity and utility of the instruments used for data
collection.
The data generated from this core unit will assist project leaders in understanding the long-term efficacy of
experimental treatments and identifying late complications after cellular therapy with HCT or genetically
modified T cells. Close coordination with the clinical Long-Term Follow-Up Program (LTFU) that provides
telemedicine services ensures prompt notification of clinical events. Integrating long-term data collection
efforts across the Projects through Core D provides efficient services to support this Research Program.

Public health relevance
PROJECT NARRATIVE The Long-Term Follow-Up Unit (LTFU, Core D) supports the Program by providing extended data collection and biospecimen acquisition services to the three Projects. Through a combination of chart review, annual surveys and active contact with participants and providers, Core D is responsible for ensuring that protocol requirements beyond the acute treatment phase (generally 2-3 months) are performed. Core D also interacts closely with Core B, which is responsible for early data collection and data analysis.